Therapeutic Delivery Platforms against Botulism

DESCRIPTION (provided by applicant): The botulinum neurotoxins (BoNTs) are the most potent protein toxins for humans and Category A select agents. There are seven serotypes of the BoNTs (termed A-G). The current penta-serotype vaccine is in limited supply and there are no approved therapies against botulism. During studies on BoNT entry into neurons, the B subunit of cholera toxin (CTB) was observed to enter BoNT-intoxicated neurons with the same efficiency as untreated cells. Since cholera toxin has been used to deliver heterologous proteins into cells, CTB or a related B subunit of the heat-labile enterotoxins of Escherichia coli (LTB) wil be developed as a platform to deliver therapies into BoNT-intoxicated neurons. The R21 component is a proof of concept to engineer a B subunit-based platform to deliver a heterologous cargo into the cytosol of a BoNT- intoxicated neuron. There are three aims: identify the most efficient B subunit for entry into BoNT-intoxicated neurons, engineer a cargo-A2 linker to assemble onto the B subunit delivery platform, and determine if the B subunit platform can deliver cargo into a BoNT-intoxicated neuron. The R33 component will optimize the B subunit as a therapy. There are 3 aims: optimize entry of the B subunit platform into neurons, optimize the cargo-A2 linker for assembly onto the B subunit platform, and deliver a pan-serotype therapy into a BoNT-intoxicated neuron and test this therapy in BoNT-intoxicated mice. Completion of this proposal will provide a platform for therapies against botulism that may also be useful as a delivery platform to treat other infectious neurological diseases and diseases of the nervous system. PUBLIC HEALTH RELEVANCE: The botulinum neurotoxins (BoNTs) are the most toxic proteins for humans. The determination that the B subunit of cholera toxin enters BoNT-intoxicated neurons provides a basis to develop a platform to deliver therapies to treat BoNT-intoxicated cells to reverse the paralysis associated with botulism. This platform may also have utility to deliver therapies against other neurological diseases.

Public health relevance
The botulinum neurotoxins (BoNTs) are the most toxic proteins for humans. The determination that the B subunit of cholera toxin enters BoNT-intoxicated neurons provides a basis to develop a platform to deliver therapies to treat BoNT-intoxicated cells to reverse the paralysis associated with botulism. This platform may also have utility to deliver therapies against other neurological diseases.